Non-Invasive Monitoring of CRISPR/Cas-Edited Chimeric Antigen Receptor T (CAR-T) Cells with Reporter Gene-Based Magnetic Resonance Imaging and Positron Emission Tomography

PROJECT SUMMARY/ABSTRACT
Clustered regularly interspaced short palindromic repeats/CRISPR associated nuclease (CRISPR/Cas) genome
editing has enabled scientists to design and build next-generation cell-based therapies. T cell-based
immunotherapies are particularly suitable CRISPR/Cas tools as after editing they can be expanded to sufficient
numbers for use in humans. Recent efforts have shown that precise CRISPR/Cas knock-in at the T cell receptor
a constant (TRAC) locus with a chimeric antigen receptor (CAR) targeted towards the B cell antigen CD19 is
more effective over randomly integrating viral-based engineered CAR-T cells in mouse models of human B cell
leukemia. Therefore, while CRISPR/Cas cellular therapies may improve patient outcomes, like traditional CAR-
T cell therapy, it is not known if every patient will respond equivalently or if some patients will be prone to off-
target, life-threatening side effects. What is needed are translationally-relevant technologies that can monitor the
fate of CRISPR/Cas-edited CAR-T cells in vivo to provide the information needed to understand patient treatment
response/non-response, relapse and/or toxicity. The long-term objective of this application is to develop
molecular imaging reporter gene technologies for non-invasive visualization of TRAC-targeted CAR-T cells in
patients. Specifically, we propose to develop novel translationally-relevant magnetic resonance imaging (MRI)
and positron emission tomography (PET) reporter gene assays to noninvasively track the fate of TRAC-edited
CAR-T cells over time and to validate these technologies in preclinical mouse models. The specific aims of this
new application are: to compare minicircle and non-integrating lentiviral CRISPR/Cas donor vectors for their
ability to efficiently edit T cells at the TRAC loci with a CD19-targeted CAR (Aim 1.1); to develop donor vectors
co-encoding our CAR, a bioluminescence reporter gene, and either the human MRI reporter organic anion
transporter polypeptide 1B3 (OATP1B3) or the PET reporter sodium iodide symporter (NIS), and to validate
TRAC-editing and functional reporter expression in vitro (Aim 1.2); to evaluate the sensitivity of OATP1B3-based
MRI and NIS-based PET for visualizing CAR-T cells in vivo, as well as perform longitudinal PET and MRI of
CAR-T cells in mouse models of B cell malignancies (Aim 2.1); and finally, to develop a dual-reporter
translationally-relevant CRISPR/Cas system and evaluate the ability to noninvasively monitor CAR-T cells in
mice with both PET and MRI (Aim 2.2). The significance of this work will be to provide powerful cell tracking
technologies to allow the fate of CRISPR/Cas-edited CAR-T cells, or other CRISPR/Cas-edited cellular
therapies, to be monitored noninvasively in preclinical models and patients. This information will allow more
precise monitoring of these transformative therapies in individual patients to better assess safety as well as to
relate cell biodistribution to patient outcomes.

Public health relevance
PROJECT NARRATIVE: This project addresses the lack of clinically-relevant tools to noninvasively visualize next-generation chimeric antigen receptor (CAR) T cell cancer immunotherapies being built using clustered regularly interspaced short palindromic repeats/CRISPR associated nuclease (CRISPR/Cas) genome editing technologies. To solve this need, we will build and validate new CRISPR/Cas systems that can efficiently engineer human T cells with a CAR at a defined DNA location that has been shown to improve the effectiveness of the therapy in animal models, in addition to co-engineering the cells with reporter genes that will make imageable proteins to permit the cells to be visible with magnetic resonance imaging (MRI) and/or positron emission tomography (PET). In the future, we predict these new imaging tools will allow doctors to better assess the long-term distribution and survival of the CRISPR/Cas-edited T cells once injected into patients, to provide critical information on their overall safety as well as their therapeutic effectiveness in individual patients.